Sickle Cell Trait Mice are More Susceptible to Chlorine Exposure and Haptoglobin Improves the Outcomes

PROJECT SUMMARY/ABSTRACT
Industrial accidents involving chlorine (Cl2) occur once every 2-3 days in the United States (US) and are
associated with higher risk of death and injuries compared to other toxicants. One out of 13 African Americans
have Sickle Cell Trait (SCT) which is the carrier state of Sickle Cell Disease (SCD). Therefore, they have a high
chance of being involved in Cl2 accidents. People with SCT are at high risk of sudden death and multiorgan
failure when exposed to stressful conditions such as high-altitude hypoxia, environmental heat, and exercise.
These injuries are mediated by acute hemolysis and rhabdomyolysis with the release of free hemoglobin and
myoglobin. Consequently, individuals with SCT can be more vulnerable to multiorgan injury and death when
exposed to Cl2. We have shown that Cl2 inhalation results in higher death rate in humanized SCD mice and that
Cl2 action is mediated by acute hemolysis. Haptoglobin is an acute phase protein that neutralizes free-
hemoglobin and myoglobin thus limiting their toxicity. As a result, haptoglobin has been approved in Europe and
Japan to treat acute hemolysis associated conditions that overwhelm the endogenous haptoglobin system.
Therefore, our hypothesis is that Cl2 inhalation induces exaggerated hemolysis and rhabdomyolysis in
humanized SCT mice resulting in increased multiorgan injury (lungs, kidneys, and heart) and death compared
to humanized normal hemoglobin control mice. We further hypothesize that postexposure administration of
haptoglobin improves the outcomes of Cl2 inhalation by scavenging free hemoglobin and myoglobin. To test this
hypothesis, we are proposing (Aim 1) to determine if humanized SCT mice are more susceptible to multiorgan
failure when exposed to Cl2 inhalation. We will test in (Aim 1A) if SCT develop exaggerated hemolysis and
rhabdomyolysis after Cl2 exposure compared to control mice, and in (Aim 1B) we will investigate whether Cl2
inhalation induces more severe multiorgan injury (lungs, kidneys, and heart) in the SCT mice compared to control
mice. In (Aim 2) we will investigate the therapeutic benefits haptoglobin administration after Cl2 exposure. (Aim
2A) will test if haptoglobin compared to vehicle reduces the long-term effects of Cl2 inhalation on the vital organs
(lungs, kidneys, and heart) by evaluating their functions and structures 14 days after Cl2 exposure. While (Aim
2B) will examine if haptoglobin reduces the death rate of SCT mice within 2 weeks of Cl2 inhalation. The work is
innovative as it will 1) show for the first time if people with SCT are at higher risk of death and multiorgan failure
when exposed to Cl2 as an example of toxic inhalants, 2) it will detail the mechanism of Cl2 induced organ injury
in SCT, and 3) it will provide a strong preclinical proof of targeted therapy, haptoglobin, for this vulnerable
population. Consequently, 4) haptoglobin can be tested in other conditions associated with acute hemolysis in
SCT and SCD population to improve their survival and quality of life towards decreasing the health disparity.

Public health relevance
PROJECT NARRATIVE Sickle Cell Trait (SCT) - which affects 1 out of 13 African Americans - is associated with high risk of sudden death and serious complications under stressful condition, which makes people with SCT vulnerable in cases of chlorine industrial accidents that happen frequently (every 2-3 days in the United States). Therefore, this study will test if humanized SCT mice are more vulnerable to death and serious organ injury following chlorine inhalation and if post-exposure haptoglobin injection negates the effect of chlorine exposure.